Manufacturable Biomimetic Microfluidic Oxygenator for Safer, Simpler Treatment of Respiratory Failure

PROJECT SUMMARY/ABSTRACT
This Fast Track STTR project focuses on developing and demonstrating a high-volume manufacturing
technology for microfluidic oxygenators for applications requiring ExtraCorporeal Membrane Oxygenation
(ECMO) to treat respiratory failure. Unlike heart disease and cancer, mortality from lung diseases continue to
rise, and a combination of increasing patient populations suffering from Chronic Obstructive Pulmonary Disease
and acute lung injury associated with respiratory infectious diseases and trauma represent an enormous health
care challenge in the US and across the world. The gold standard treatment for respiratory failure, invasive
mechanical ventilation, carries significant risks of mechanical and biochemical injury to the lung along with
microbial exposure. As a result, ECMO has emerged as an alternative therapy that allows injured lungs to rest,
directly oxygenating and removing carbon dioxide from the blood in an extracorporeal circuit. However, ECMO
use is limited due to the extreme complexity of the blood circuit, which includes a hollow fiber membrane
oxygenator (HFMO) as the functional unit, and bioinspired microfluidic oxygenators capable of more safely
oxygenating the blood have emerged. Our preliminary data demonstrates the first large-scale, extended duration
microfluidic oxygenators in large animals, with distinct safety and efficacy advantages over HFMO, but the
method of construction is very complex and costly. We have engaged with high precision injection molding
companies to identify a path to produce the devices at high volume and low cost, and the focus here is to develop
and demonstrate the injection molded microfluidic oxygenator technology in safety and efficacy studies in a
porcine model. Toward this end, we propose a fast track proposal comprising two phases and four overall aims.
In Phase I, we will 1) Define the target product profile for the adult clinical scale microfluidic oxygenator and
conduct fluid mechanical and thermal modeling to identify the process window required for high yield injection
molding of these devices, 2) Iteratively apply computational models to verify the oxygen transfer and blood flow,
pressure and shear properties of oxygenators resulting from these designs, and 3) Build a casted replica of the
injection molding design to confirm gas transfer performance. Successful identification of a microfluidic
oxygenator design that meets the requirements from manufacturability, cost and performance perspectives will
lead to advancement to Phase II of the program. Here we will 1) Fabricate the injection molds required for
fabrication or larger numbers of microfluidic oxygenators at pediatric and adult scale, and 2) Test these pediatric
and adult scale oxygenators in extended duration studies in porcine models to confirm safety and efficacy in
comparison with HFMO control devices. This demonstration of safety and efficacy, enabled by the high-volume
injection molding process developed on this project, will accelerate the advancement of the technology toward
commercialization and clinical translation for treatment of critically ill patients suffering from respiratory failure.

Public health relevance
PROJECT NARRATIVE The goal of this STTR project is to develop and demonstrate a manufacturable technology for producing microfluidic oxygenators for commercial applications in the treatment of acute and chronic respiratory failure, one of the most significant health care challenges in the world. This project leverages three-dimensional branching channels that mimic the physiology of the natural vasculature, a technology that has been shown in research prototypes to have superior efficacy to conventional artificial lung devices. The development and implementation of the manufacturing technology, using high precision injection molding, will enable cost- effective and large-scale production to address this urgent medical need and rapidly growing market.